Physical Genomics and Engineering Training Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The mission of the “Physical Genomics Predoctoral Training Program” (PGTP) is to train the next generation of transdisciplinary scientists that will bridge molecular biology, bioengineering, physics, optics, chemistry, and medicine. Through collaboration of program faculty in the McCormick School of Engineering and Applied Sciences, the Feinberg School of Medicine and the Weinberg College of Arts and Sciences, the PGTP aims to enable trainees to acquire and apply a broad skillset that addresses the physical manipulation of living systems in the pursuit of new strategies for the treatment of disease.
Physical genomics is a new field that involves understanding the structure, function, and fundamental principles of chromatin, an intricately folded group of macromolecules including DNA, RNA, and proteins that houses genetic information within cells and determines which genes get suppressed or expressed. With this understanding, researchers can reversibly regulate, control, and even reprogram global patterns of gene expression without altering the genes themselves. This has wide implications in the treatment of diseases such as cancer and Alzheimer’s.
The PGTP will deploy a range of strategies to help trainees integrate practical, hands-on experience with the knowledge base required to advance research in physical genomics. Through an evidence-based approach to training, trainees will participate in experiential learning and seminars focused on reprogramming chromatin to treat disease and engineer living systems to overcome environmental challenges using breakthrough optical imaging, computational genomics, and molecular biology. Four second-year graduate students will be appointed to the grant for two-year terms each year. Trainees will be mentored by faculty with an outstanding record of productivity and mentorship. Program mentors will provide ongoing review, evaluation, and mentoring of trainees with the goal of creating a resilient cadre of scientific professionals.
The ability to regulate the physical structure of chromatin represents a new frontier in biological discovery and has the potential to be one of the major drivers of 21st-century biotechnology. The PGTP aims to position its trainees as the next generation of interdisciplinary biomedical leaders able to explore this frontier through an exceptional training experience in physical genomics.

Public health relevance
PROJECT NARRITIVE The proposed Physical Genomics Predoctoral Training Program will support the transdisciplinary training in molecular biology, bioengineering, physics, optics, chemistry, and medicine with the goal of providing an understanding of systems and integrative biology in the context of the emerging field of physical genomics.